RR&D Research Career Scientist Award Application

Dr. Twamley bridges neuropsychology and rehabilitation research by developing Compensatory Cognitive
Training (CCT/CogSMART) interventions and conducting randomized controlled trials to test their efficacy in
improving cognition, everyday functioning, and quality of life. These outcomes are important to Veterans, their
loved ones, clinicians, VHA, and society, as cognition and functional abilities are directly related to disability
and community integration. Indeed, cognitive health is considered a “third pillar” of health, alongside physical
health and mental health, and is considered vital in the VA’s Whole Health approach to healthcare. Dr.
Twamley’s currently funded studies are all focused on Veterans with cognitive impairment (e.g., due to
traumatic brain injury, mild cognitive impairment, Parkinson’s disease, hoarding disorder, or other mental
health conditions). She is currently PI or Co-PI of studies funded by VA RRD, VA CSRD, Department of
Defense, and the National Science Foundation, and serves as a Co-Investigator on studies funded by VA
RRD, VA CSRD, and DoD. Her research uses intervention manuals she and her colleagues developed to
target impairments in prospective memory, attention, learning and memory, and executive functioning, which
have shown efficacy in multiple domains of cognition and functioning in multiple neuropsychiatric populations.
Many of the compensatory strategies taught are simple habits used by many successful people (e.g., using a
calendar system for all scheduling and checking it regularly; using organizational approaches to learning and
remembering; planning to meet goals and deadlines by listing goal steps and assigning them due dates). Her
current RRD Merit Award focuses on CCT for homeless Veterans with mental health conditions receiving
residential mental health rehabilitation and treatment; her current CSRD Merit Award trial is examining
Motivationally-Enhanced CCT for older Veterans with mild cognitive impairment, and combines compensatory
cognitive strategies with lifestyle strategies (e.g., physical activity, nutrition, and sleep-related behaviors to
reduce dementia risk). Her newer work seeks to find new ways of implementing cognitive rehabilitation
interventions (e.g., in combination with pharmaceuticals targeting brain inflammation; in combination with other
psychosocial rehabilitation interventions; compensatory cognitive training in combination with computerized
cognitive training; delivery via mobile app or telemedicine; briefer, more personalized interventions; delivery via
cognitively assistive robots). Other research interests include cognitive impairment and disability in homeless
Veterans, supported employment to assist those with cognitive impairments in returning to work, cognitive
impairment in PTSD, and the use of technology to improve cognition and mental health. Dr. Twamley has a
rich network of collaborators locally, nationally, and internationally, and she collaborates with researchers and
clinicians worldwide to develop, adapt, translate, and disseminate cognitive health interventions. Additionally,
she commits considerable time and effort toward mentorship of the next generation of VA clinical rehabilitation
scientists dedicated to improving cognitive health in Veterans. Her service activities include scientific peer
review for the VA and other agencies, administrative service to multiple professional organizations, and local
service on the VA Research and Development Committee. Dr. Twamley combines extensive research
experience and a high level of scientific productivity with dedication to effective mentorship and support to the
clinical, research, and training missions of the VA, with the ultimate goal of improving health and quality of life
for our nation’s Veterans.

Public health relevance
Dr. Twamley’s research focuses on cognitive rehabilitation interventions to improve cognition, functioning, and quality of life for Veterans with neuropsychiatric disorders (e.g., brain injury, mental illness, mild cognitive impairment). In addition serving as PI on five funded Veteran-focused awards, she collaborates with VA and university researchers and clinicians locally, nationally, and internationally to advance and disseminate cognitive health interventions. Dr. Twamley demonstrates strong commitment to mentorship and plays an active role in the academic development of the next generation of clinical researchers, including predoctoral students, postdoctoral fellows, and junior faculty career development awardees. In addition to research, clinical dissemination, and mentorship, she devotes considerable time to service to the VA, university, and profession. Dr. Twamley will continue to focus on rehabilitation research to improve healthcare for Veterans with neuropsychiatric disorders so they may reach their highest potential social and occupational functioning.